Elucidating the Structural Requirements for Next-Gen Glycoconjugate Vaccines

Elucidating the Structural Requirements for Next-Gen Glycoconjugate Vaccines
Project Summary
Glycoconjugate vaccines provide enormous health benefits globally, although they have been less
successful in some populations at high risk for developing disease. In most cases, conjugation of the sugar
antigen to the carrier protein has been done empirically with little attention on variables critical for the
immune response. Recent findings from our lab offer a new and rational explanation for how conjugates
work. The new model suggests that carbohydrate presentation to T cells by antigen-presenting cells may
strongly enhance the efficacy of antibody responses. Application of this principle in mouse models of group B
streptococcal disease and Francisella tularensis infection by using a carrier peptide rather than a protein,
resulted in vaccines more protective than standard glycoconjugate vaccines. We have also demonstrated the
critical role of the peptide linker and the conjugation site in enhancing both the conjugation efficiency and the
immune response to vaccines. The results support the notion that peptide glycoconjugate vaccines provide
superior protection against bacterial challenges. Remarkably, the use of a peptide instead of a protein as a
carrier confers better protection at much lower levels of carbohydrate specific IgG. This observation
challenges the paradigm of a direct correlation between the amount of IgG induced by a glycoconjugate and
protection. A comprehensive evaluation of antibodies and immune cells generated by protein vs peptide
glycoconjugates will clarify the features that make peptide vaccines extremely potent. We will evaluate the
antibody response to glycopeptide vaccines in terms of IgG subtypes, affinity, avidity and functional activity,
as well as, elucidate the costimulatory/coinhibitory molecules being expressed on memory B cells and relate
this to the functionality of the antibodies being made. This approach will define the characteristics that make
glycopeptide-induced antibodies so potent and forms the basis for screening of B-cell hybridomas produced
from peptide vs protein glycoconjugates. Correlates of highly functional antibody and critical B cell
biomarkers will be identified. Hybridomas that produce antibodies with different degrees of protective activity
will be evaluated by BCR sequencing. Fab fragments of low and highly effective antibodies will be co-
crystallized with GBSIII oligosaccharide to investigate the role of epitope specificity in protection. We will
apply our studies of these peptide/polysaccharide conjugates to create more efficacious and longer lasting
immunity to glycoconjugate vaccines. !
!

Public health relevance
Elucidating the Structural Requirements for Next-Gen Glycoconjugate Vaccines Project Narrative We are proposing to define immunologic mechanisms responsible for glycoconjugate vaccine processing and presentation leading to optimal T helper–cell reactivity. In this study, we will develop an understanding of polysaccharide epitope interactions with highly efficacious antibodies. Our basic discoveries will lead to new, more effective glycoconjugate vaccines against important pathogens.